Protection against early SIV brain injury with adjunctive therapy to cART

Project Summary
Prevention of HIV-associated neurocognitive impairment (HIV-NCI) remains elusive, despite the efficacy of
cART in suppressing viral replication within the CNS. Although cART initiated immediately after HIV infection
(INSIGHT START study) profoundly reduced disease progression, there was no neurocognitive advantage
over delayed cART. Acute brain injury occurs within weeks of infection (HIV, SIV), before cART suppression is
typically achieved. Spontaneous limited recovery may occur thereafter, suggesting a therapeutic window for
rapid-acting neuroprotective treatments. These have not yet been tested. Our overall objective is to determine
the ability of a rapidly-assimilated neuroprotective drug (dimethyl fumarate/DMF, FDA-approved), in
combination with cART, to reduce injury and promote recovery in acute SIV infection in rhesus macaques.
SIV/HIV injury is linked to oxidative stress and inflammation, which DMF can target through enhancing Nrf2-
driven antioxidant enzyme expression and associated antioxidative/anti-inflammatory pathways. In our human
brain autopsy studies, HIV-NCI associated with reduced expression of heme oxygenase-1 (HO-1), an
antioxidant enzyme with two isoforms (HO-1 and -2), and with increased neuroinflammation. Moreover, HIV
infection without HIV-NCI associated with increased HO-1 levels, consistent with a neuroprotective role for HO.
In a separate cohort of persons living with HIV (PWH), we showed that an HO-1 promoter variation ((GT)n
dinucleotide repeat)) that enhances HO-1 expression, associates with lower neuroinflammation and lower HIV-
NCI risk. In acute HIV infection (in vitro) we showed that DMF induces HO-1 and other Nrf2 antioxidant
enzymes in infected macrophages, and reduces TNF and glutamate release, thus linking enhanced enzyme
expression with neuroprotection. In acute SIV infection in rhesus macaques, we defined a potential therapeutic
window for DMF enhancement of antioxidant responses. We identified unique patterns of acute synaptic injury
linked to low antioxidant enzyme levels, and changes in expression. Brainstem injury associated with higher
neuroinflammation, lower enzyme levels, and progressive loss of HO-2. Recovery associated with stable HO-2
and increasing HO-1 levels. In our pilot macaque treatment study, DMF induced brain antioxidant enzymes,
including HO-1, reduced oxidation of DNA and proteins, and produced a less-oxidized brain redox state. These
findings support testing DMF as an adjunct to early cART. We hypothesize that DMF therapy concurrently with
cART in acute SIV infection will reduce oxidative stress and acute neuronal injury while enhancing neuronal
recovery throughout the brain. We will determine effects of concurrent DMF/cART on: (Aim 1) regional brain,
oxidative injury, inflammation, neuronal integrity, signaling and recovery, and association with plasma markers
of injury, oxidative stress and microbial translocation; (Aim 2) brain localization of immune cell infiltration, cell
activation and oxidative injury in immune, endothelial, glial, and neuronal subtypes; and (Aim 3) infiltration of
SIV-infected immune cells in brain and lymphatic tissue, in acute SIV infection of rhesus macaques.

Public health relevance
Project Narrative Prevention of HIV-associated neurocognitive impairment (HIV-NCI) remains as an elusive therapeutic goal in HIV treatment because even early introduction of combined antiretroviral therapy (cART) gives incomplete protection to the brain. Brain injury can begin soon after initial HIV infection, and inclusion of a rapidly-acting neuroprotective agent with cART initiation as soon as possible after HIV infection is likely necessary for maximum brain protection. We have shown that dimethylfumarate, an FDA-approved drug used in the treatment of multiple sclerosis, shows promise as a suitable neuroprotective agent in the rhesus macaque model of early brain injury caused by immunodeficiency virus, which could lead to future neuroprotection studies in persons living with HIV.